CENTER OF EXCELLENCE IN DIABETES AND OBESITY RESEARCH: CORE D

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Major functions of the Animal Core Facility (Core D), is to house, breed, genotype and provide mouse models of diabetes and obesity.